Mechanism of action of a microbiota-directed complementary food that promotes ponderal growth in Bangladeshi children with moderate acute malnutrition

PROJECT ABSTRACT
144 million children suffer from undernutrition, a condition with numerous long co-morbidities. A delay in
growth, including stunting of height and wasting of weight, is one of the most prominent morbidities of
undernutrition. While current therapeutics against undernutrition have reduced mortality, they have had very
limited efficacy in repairing the associated morbidities. Recent studies have indicated that undernutrition is also
associated with failed gut microbiota development, resulting in undernourished children having an immature gut
microbiota. Research efforts in mice have shown that transplanting immature gut microbial communities
transmits the growth faltering phenotypes seen in undernourished children. Repair of microbiota immaturity could
represent a new therapeutic strategy for treating childhood growth delays caused by undernutrition.
To investigate whether more mature gut microbiota could rescue this delayed growth, the Gordon Lab
designed a series of microbiota-directed complementary foods (MDCF) that were able to repair microbiota
immaturity. Recently, we performed a proof-of-concept controlled feeding trial where undernourished
Bangladeshi children consumed either our most promising MDCF (MDCF-2) or a ‘standard’ ready-to-use
supplementary food (RUSF) not designed to repair microbiota immaturity. MDCF-2 produced a significantly
greater rate of weight gain than RUSF even though MDCF-2 has a lower caloric density than RUSF. This study
also revealed 23 bacterial strains whose abundance in the gut was associated with host weight changes.
Recently, it was also shown that MDCF-2 has a different set of carbohydrates compared to RUSF. These very
encouraging results provide the motivation for this proposal which seeks to better understand the genomic
features of these weight-associated taxa and uncover the mechanisms by which they respond to MDCF-2.
Given that the gut microbiota plays a key role in processing of dietary polysaccharides and that
differences in carbohydrate-associated enzymes (CAZymes) gene repertoires are known to affect bacterial
fitness, I hypothesize MDCF-2 promotes host weight gain through the presence of specific bioactive
carbohydrates that are metabolized by CAZymes in growth-promoting members of the developing microbiota.
The goal of this proposal is to identify these putative weight-promoting CAZymes first in silico and then validating
those CAZymes in vitro and in vivo. In Aim 1, I seek to computationally identify CAZymes associated with weight
gain, characterize the genomes of their ‘host’ bacterial strains, and characterize their expression in the gut. In
Aim 2, I will directly test whether bacterial strains containing these CAZymes promote weight gain in gnotobiotic
mice fed a diet supplemented with MDCF-2. This effort to identify specific microbes containing growth-promoting
CAZymes will allow us to develop effective therapeutic foods in different populations of undernourished children
and expand our understanding of the mechanisms by which the microbiome influences postnatal development.

Public health relevance
PROJECT NARRATIVE Childhood undernutrition is a pervasive, pressing global health challenge whose associated morbidities (immune and metabolic dysfunction, stunting, neurodevelopmental abnormalities) are inadequately treated with current interventions. The contribution of the gut microbiota to pathogenesis is underexplored. This project seeks to understand (i) mechanisms by which a promising microbiota- directed complementary food (MDCF-2) is able to significantly improve the weight gain in children with moderate acute malnutrition, (ii) how biotransformation of its component glycans influences postnatal microbiota and host development and (iii) how to design next-generation MDCFs.